2024 SenNet CODCC Supplement

SenNet 2024 CODCC Supplement Abstract
The purpose of the Supplement is to further the CODCC Administrative Core (Sub-Section
C: Administrative Core: Including Consortium Coordination & Outreach) in three areas:
1. integration and expansion of murine activities and additional awards across the
consortium,
2. management and growth of the comprehensive, nationwide, undergraduate scientific
internship award program in cellular senescence,
3. expanding opportunities to gather, in person, the consortium and pharmaceutical
companies and related biotechnology businesses, focused on cellular senescence drug
discovery and manufacture.
Given the expansion of the consortium focused on murine and additional single cell data
platforms, additional support and coordination will be required to handle the rapid growth in
the development of the broader overall SenNet eco-system. This includes coordination with
other single cell platforms at a larger scale to best serve the expanded SenNet Consortium
adding substantive murine focus, combined murine and human foci, and the broader
research community.
Internships will allow learning valuable new skills across the scientific research spectrum
and gain experience in an educational lab environment. During the internship program,
students will conduct cutting-edge research, greatly expanding their knowledge of biology
and data analysis. Students will develop various skills throughout the summer.
CODCC received significant input in year two in working groups and from NIH regarding the
consortium’s interest in meeting in-person more often, and particularly in focused areas
among awards and outside parties with shared interest. These interests also cover
senescence biology relevant to pharmaceutical development and manufacture. Following
through on this will require additional management of meetings, workshop/panels/working
groups, & data-thons and hackathons. To achieve these aims will also require expansion of
communication and engagement to other common fund consortia, among the vendor
ecosystem, and to the public interested in the science of Cellular Senescence and its human
impact.

Public health relevance
SenNet CODCC Supplement Project Narrative The purpose of the Supplement is to further the CODCC Administrative Core in three areas: 1. onboarding and integrating new additional murine awards; 2. management and growth of the CUSP Consortium Underrepresented Student Program; 3. expanding in person consortium activities, in particular to include engagment with the corporate ecosystem including pharmaceutical development related to Cellular Senescence.